Cell and Tissue Microscopy Core

ABSTRACT
The Cell and Tissue Microscopy Core (CTMC) will support the DC-IDDRC researchers in their work that relies
on the use of high-resolution optical and electron microscopic approaches to study cells and tissues. CTMC
will offer access to state-of-the-art microscopy imaging and analytical tools to support research focused on
pediatric diseases with an emphasis on neurodevelopmental disorders, fetal and neonatal brain injury and
genetic diseases. CTMC will extend its services to researchers at Children’s National Hospital, George
Washington University, Georgetown University and Howard University. Among these users, there is a growing
need for tools that enable imaging at greater spatial and temporal resolution while also allowing functional
imaging and deep as well as large area imaging. To support these needs CTMC continues to expand its
services including widefield, confocal, live and multiphoton microscopy with optogenetic manipulation, light
sheet microscopy, super resolution, correlative light and EM as well as large field 3D-EM. With these
developments the core will continue to meet and also expand its mission to enable structural and functional
imaging from nanoscale to organismal scale that are aimed at understanding and treating defects leading to
IDDs. The core will also help develop and implement quantitative analytical approaches for image visualization
and data analysis. The core will also participate in collaborative IDD-relevant projects that heavily rely on the
use of newer technologies. A significant mission of the core will be to train next generation of researchers in
the use of advanced microscopy approaches through offering hands on training, educational workshops
organized by the core in collaboration with other companies and researches in the greater DC region. CTMC
will also collaborate with other DC-IDDRC cores including the Human and Animal Imaging Core,
Neurobehavioral Core and Genomics and Bioinformatics Core to serve projects with cross disciplinary needs.
Through above endeavors CTMC aims to continue leveraging technological developments in microscopy to
enable conception, design, and implementation of these developments to tackle challenges in the field of IDD
research and further the mission of DC-IDDRC.